STRUCTURE OF BIOMACROMOLECULAR FUNCTION &ACTIVITY

The general research interests of our group are to determine the structure of biological molecules, including nucleic acids, enzymes, RNA(DNA)protein complexes and clinically important enzyme drug complexes, using NMR and various other biophysical and biochemical methods. The knowledge of these biological structures will help us to understand the structural basis for the function of biological molecules and complexes.